Surfactant Protein C Mutations and Interstitial Lung Disease

ABSTRACT
Idiopathic pulmonary fibrosis (IPF) is a progressive scarring interstitial lung disease (ILD) that affects mainly
older adults for which there remains a significant unmet therapeutic need. While the pathophysiologic
underpinnings of IPF remain incompletely understood, an additional critical barrier to developing better
therapeutic outcomes for IPF has been a dearth of translationally relevant preclinical models. Based on a recent
paradigm shift wherein the concepts of repetitive injury to a dysfunctional, vulnerable, alveolar epithelium coupled
with an abnormal wound healing response are postulated as disease “drivers”, new opportunities are emerging
for therapeutic discovery in IPF. Over 60 mutations in the alveolar type 2 cell (AT2) restricted, Surfactant Protein
C [SP-C] gene [SFTPC], have been found in sporadic and familial IPF and provide important clues for
understanding IPF pathogenesis. To address the unmet need for veterans with IPF, this proposal builds upon
on a strong foundation of our prior work funded by this Merit Review program characterizing the cell biology of
SP-C biosynthesis that culminated in generation of two novel knock-in mouse models of spontaneous lung
fibrosis already in hand which express clinical SP-C mutants in AT2 cells in an allelic and inducible fashion. Our
Published Data has demonstrated that clinical, IPF-associated SFTPC mutations produce aberrant SP-C
proprotein isoforms that functionally segregate into 2 AT2 cell stress phenotypes: ER stress induced by
intracellular SP-C misfolding (“BRICHOS”) or impaired autophagy/mitophagy secondary to proSP-C
mistrafficking to non-native organelles (“Non-BRICHOS”). When expressed in the lung epithelium in vivo, both
the non-BRICHOS mutant (SftpcI73T) and the BRICHOS mutant (SftpcC121G) are extremely toxic to the lung and
each is sufficient to evoke a time-dependent, physiologically restrictive peripheral fibrotic lung phenotype that
elaborates translationally relevant biomarkers reported in human IPF. Building on this, our Merit Review renewal
will now leverage these Sftpc mutant mice to map distal lung cell populations in IPF while also identifying and
translating molecular mechanisms linking the disrupted cellular quality control, epithelial dysfunction, and
pathophysiology of IPF/ILDs. In 3 specific aims, our experimental approach will be to exploit the unique features
of these genetic models combined with tools and reagents available in our program designed to interogate cell
quality control and integrated stress responses to first define key alveolar niche cell populations emerging during
initiation, injury amplification, and fibrosis stages induced by SP-C mutations in vivo [Specific Aim 1]. Then
armed with this functional map we will couple Sftpc mice with reductionist models such as AT2 organoids to
define the role of endogenous endoplasmic reticulum (ER) stress in AT2 dysfunction and the aberrant
injury/repair pathways found in IPF [Specific Aim 2]. Finally, we will assess the downstream consequences of
disrupted epithelial cell quality control for AT2 metabolic reprogramming and mitochondrial dynamics and then
contextualize their impact on AT2 phenotypes and fibrotic remodeling [Specific Aim 3]. As alveolar epithelial
dysfunction has not been studied extensively in vivo in the setting of fibrotic lung diseases, this approach offers
the unique opportunity to comprehensively identify unique mechanisms mediating responses to the mutant
SFTPC substrate by AT2 cells, and to assess the pathways promoting crosstalk between AT2 cells, inflammatory
cells and fibroblasts that drive parenchymal remodeling. By understanding the path to epithelial injury from
mutant SP-C, the mechanisms identified using these models can be cross-purposed to better understand IPF
pathogenesis in general, promote identification of new target pathways, and test novel IPF therapies.

Public health relevance
NARRATIVE Idiopathic Pulmonary Fibrosis (IPF) is a devastating lung disease of older veterans marked by progressive respiratory failure for which there remains a significant unmet need for effective medical therapies. Lung epithelial cell dysfunction has emerged as an important causal contributor to the development of fibrotic lung scarring. In order to improve our understanding of IPF, we generated two novel mouse models expressing IPF-associated mutations in the lung epithelial cell restricted Surfactant Protein C gene (SFTPC). Using this preclinical platform we will characterize the mechanisms underlying lung epithelial dysfunction found in SFTPC mice including abnormal cellular quality control responses (e.g. endoplasmic reticulum stress, autophagy, mitophagy) and metabolic reprogramming. Results funded by this project will permit rapid identification of new cell populations, signaling pathways, and molecular targets thus accelerating the discovery of new IPF treatments.